Administrative Core

PROJECT SUMMARY/ABSTRACT
Our NIH NCTRI Center is well-integrated within and administered through the Center for Reproductive Sciences
in the Department of Obstetrics, Gynecology and Reproductive Sciences at the University of California, San
Francisco. The purpose of the Administrative Core is and will be to provide administrative, financial, and
organizational support for the investigators and technical staff engaged in our NIH P50 NCTRI Center's research
projects and supporting cores. Day-to-day operation of the Administrative Core involves and will continue to
involve coordinating all administrative, financial, and compliance aspects of the award. In conjunction with the
NCTRI Center Director and the Program Administrator, the Department, and the Center for Reproductive
Sciences, the Core will continue to implement an operating framework to ensure that expenditures are consistent
with the intent of the award and the guidelines and regulations that govern the use of funds, as well as any
institutional and federal requirements. In addition, the Core will continue to organize our monthly P50 NCTRI
Steering Committee meetings of the PI/Center Director, Associate Director and all Project and Core Directors,
as well as the annual Center for Reproductive Sciences Research Retreat, research meetings, and presentations
of our P50 investigators and trainees. The Administrative Core personnel will continue to provide support to the
Pl, Project and Core Directors, trainees, technical staff, and all Cores in our NIH P50 NCTRI Center at the
University of California, San Francisco.

Public health relevance
PROJECT NARRATIVE The Core is highly relevant to our UCSF NCTRI mission as it enables operationally, administratively and financially, our NCTRI researchers, trainees and staff.